Measurement and Analytics Core

Abstract: The Yale Measurement and Analytics Core (MAC)
The quality of the data obtained from a study is inextricably linked to the quality of measurement that is used.
Psychometrically sound measures improve data quality in numerous ways including ensuring that constructs
are measured accurately and dependably and reducing measurement error that could impact findings. In turn,
employing proper statistical methods allows us to draw meaningful and impactful conclusions from our data to
further scientific knowledge. The Measurement and Analytics Core – the first of its kind – will uniquely prioritize
these key aspects of scientific inquiry as a Core to ensure the integrity of the research generated by the Yale
Center for the Study of Tobacco Products and directly increase its utility for informing the FDA's regulatory
efforts. The MAC comprises two teams - The Measurement Team and the Analytics Team. Both teams will
contribute to each of the Core's three specific aims: (1) to ensure the use of validated measures and statistical
procedures across projects and pilot studies to increase the scientific rigor, interpretability, and impact of
findings, (2) to develop novel psychometrically sound measures and statistical approaches to address pressing
needs in Tobacco Regulatory Science, and (3) to provide training in measurement, statistics, and the use of
nationally representative data (i.e., The Population Assessment of Tobacco and Health Study [PATH]) to
address Tobacco Regulatory Science research questions. In addition to ensuring the quality of the science
generated by our Center and advancing the measurement and statistical knowledge and actionable skills of
our faculty and trainees, the MAC will widely disseminate its new measures, statistical methodology, and
didactics through publications and other outlets (Coordinating Center webinars, the TRS Knowledge Center
website, measurement banks like the PhenX Toolkit, NIH Toolbox®, or PROMIS®) to enhance the overall
quality and impact of Tobacco Regulatory Science and to facilitate cross-TCORS collaborations. The success
of the MAC will be driven by the expertise of its members. The MAC will be led by Drs. Meghan Morean and
Ralitza Gueorguieva, who will lead the Measurement Team and Analytics Team, respectively. Dr. Morean is an
expert in the development and psychometric evaluation of self-report measures to improve the quality of
substance-related research. Of note, she developed a novel measure of e-cigarette dependence, the only e-
cigarette related measure adopted into the prestigious PROMIS® measurement bank. Dr. Gueorguieva is an
expert in statistical modeling, data visualization, and applying innovative statistical approaches to Tobacco
Regulatory Science. She has led all statistical efforts for Yale TCORS 1.0 and 2.0 and has more than 20 years
of highly productive collaborations on human lab experimental studies, clinical trials, and observational studies.
The MAC also will be supported by Drs. Grace Kong (expert in qualitative research and survey methodology),
Eugenia Buta (expert in complex data analysis, data visualization, and statistical methodology) and Patricia
Simon (expert in advanced longitudinal research methods and use of PATH general and restricted datasets).